Core B - Clinical Core

PROJECT SUMMARY – CLINICAL CORE (CORE B)
The primary objective of the Wisconsin Alzheimer’s Disease Research Center (ADRC) Clinical Core is to provide
access to well-characterized, diverse participants with standardized clinical, cognitive, and neurobehavioral data
coupled with neuroimaging (magnetic resonance imaging [MRI], positron emission tomography [PET]),
cerebrospinal fluid (CSF), blood, and DNA data that are linked to electronic health records (EHR) and consent
to brain donation to facilitate translational AD research in preclinical identification and early diagnosis and
intervention. To that end, the Core conducts clinical evaluations in patients with mild dementia and mild cognitive
impairment (MCI), as well as in cognitively unimpaired older (O-CU) (>65 years) and middle-aged (M-CU) adults
(45-65 years). The Clinical Core works closely with all ADRC Cores to facilitate the mission of the Center by
participating in outreach, recruitment, and screening activities; conducting standardized UDS clinical, cognitive,
and neurobehavioral assessments; gathering ancillary aging-related cognitive and clinical data; coordinating
neuroimaging and fluid biomarker collection; consenting Core participants for brain donation; facilitating and
consulting on cognitive testing, CSF collection, and disclosure processes; identifying patient and caregiver dyads
for care research; promoting linkage of EHRs to research data; providing faculty mentors and clinical research
resources to research trainees; and ensuring timely availability of participants, data, and biospecimens to
investigative teams. In the next grant cycle, the Core will accomplish the following aims: Aim 1: Conduct detailed
annual (dementia, MCI, O-CU) or biennial (M-CU) clinical assessments with diverse participants and facilitate
consent to link to EHRs to characterize longitudinal clinical trajectories and functional outcomes. Aim 2: Facilitate
consent for brain donation across all participants and collection of longitudinal biennial biomarker data (MRI,
CSF, blood) in MCI, O-CU, and M-CU participants, and one-time biomarker data in dementia participants.
Facilitate collection of amyloid and tau PET in a subset of Clinical Core participants with MRI. Aim 3: Provide
CSF Collection, Neuropsychology, and Disclosure Services to investigators to facilitate implementation of
standardized quality data collection, training of study staff, and/or disclosure of research test results to
participants. Aim 4: Integrate culturally-tailored assessment and education approaches to support Core
participants from diverse, under-represented communities to encourage long-term engagement and retention in
clinical and biomarker assessments. Incorporate feedback from participant advisory councils and
underrepresented minority communities to foster ongoing relationships with participants and provide relevant
education and feedback to the community. Aim 5: Align data collection with national ADRD research initiatives
to facilitate collaborative research and expedite sharing of data and resources with the National Alzheimer’s
Coordinating Center, the National Centralized Repository for Alzheimer’s Disease and Related Dementias, and
other ADRCs and investigative teams.